The LS2 initiative: an open-source light-sheet microscope for imaging across scales

PROJECT ABSTRACT
Biological tissue is organized over scales of nanometers to centimeters. Understanding individual cells and multi-
cellular organization requires simultaneously probing the architecture of tissue across these spatial scales.
Recent advances in tissue clearing, expansion, and fluorescence labeling are providing unprecedented access
to structural and molecular information from intact tissues. These methods have the potential to accelerate new
discoveries across diverse fields of research. Within neuroscience, these techniques offer new possibilities to
map neural circuits from synapses to the whole mouse, primate, and human brain. However, fully harnessing
molecular imaging across three-dimensional samples at scale requires new advances in microscopy. Standard
microscope objectives have limited working distances (< 1 mm) and fields of view (< 1 mm). Therefore, imaging
large tissue volumes at high resolution typically requires physical sectioning and extensive image tiling, both of
which severely complicate large-scale volumetric imaging. These technical constraints often limit current imaging
technologies to imaging small (mm3) volumes at high resolution (<1 µm) or large (cm3) volumes at lower
resolution (>1 µm). To address this need, we have developed a new large-scale light-sheet (LS2) microscope.
Our LS2 system enables diffraction-limited and aberration-free imaging of centimeter-scale tissues with high
contrast, resolution, speed, and ease-of-use (i.e., no tissue sectioning and minimal image tiling) - attributes that
are currently unattainable with existing imaging technologies. By leveraging highly engineered lenses and
camera sensors from the electronics metrology industry, the LS2 system achieves a field of view of 10.6 x 8.0
mm (30x larger than previous systems) and 35 mm working distance (10x larger) with a near-isotropic resolution
of 1.0 x 1.0 x 2.5 µm. Including stage movement, the system can access a 200 x 52 x 35 mm3 volume without
sectioning, at up to 1 gigavoxel/sec. While the LS2 system was designed at the Allen Institute for Neural
Dynamics for brain-wide imaging and reconstruction of neural circuits in the mouse brain, it will also be
transformative for an array of scientific questions being pursued by many other investigators and institutions.
However, for the LS2 system to drive scientific discovery, it is imperative to offer well-documented, supported
hardware and software designs, alongside educational resources—elements crucial to lowering the adoption
barrier. The work proposed here will support these efforts, thereby allowing us to maximize the scientific impact
of a recently optimized and re-engineered and optimized LS2 system.

Public health relevance
PROJECT NARRATIVE Microscopic examination of cells, organs, and entire organisms is the gold standard for probing the mechanisms that underly diseases states and the response of diseased cells and tissues to treatments. Our recently re- engineered and optimized large-scale light-sheet (LS2) microscopy system enables us to examine these specimens with unprecedented scale and detail, capabilities which would be transformative for many investigators and institutions. This project will expedite dissemination and establish a foundation for future innovations in large-scale imaging based on the LS2 system.